Optimizing Collaborative Care for Youth with Persistent Post-Concussive Symptoms

PROJECT SUMMARY/ABSTRACT
More than 1 million U.S. youth sustain a concussion each year, and up to 30% experience persistent post-
concussive symptoms (PPCS) such as headache, fatigue or difficulty focusing lasting one month or more.
PPCS can interfere with normal adolescent development, resulting in issues with social and emotional
dysfunction and even school failure. Despite these concerns, few evidence based treatments are available for
youth with PPCS. We have conducted extensive work using a collaborative care (CC) framework integrating
mental health care into a medical model, and we adapted this approach for youth with PPCS, combining
concussion-focused cognitive behavioral therapy (cf-CBT), parenting skills training (PST) and care
management (CM) to create wraparound treatment for youth with PPCS that could be delivered either in-
person or virtually (using video conferencing software). We completed an R01 funded RCT with the CC
approach, finding effectiveness for treating youth with PPCS, with improvements in concussive symptoms and
quality of life at one year, and 60% of participants completing the intervention completely virtually. Of note, this
intervention is unique in that two of the components are focused on parents or parents and youth together
(PST, CM), and only one of the components (cf-CBT) is solely youth focused. We are now proposing to
optimize and refine the CC approach, conducting a high efficiency MOST (multiphase optimization strategy)
trial to assess the contribution of each of the three components (cf-CBT, PST and CM) to effectiveness of the
intervention, thereby allowing us to streamline the intervention to only include active components. The analysis
will be 23 factorial, with three intervention components and two levels of each (present or absent), resulting in 8
possible treatment combinations. The benefit of the MOST approach is that it combines all youth who receive a
component, allowing us to assess all treatment components with only a modest sample size. We will recruit
368 youth with PPCS from two geographic locations (Seattle and Dallas), randomizing them to one of 8
treatment groups. Youth and/or parents will attend treatment sessions via video conferencing software over
three months, and complete surveys regarding primary outcomes (concussive symptoms and health-related
quality of life) and secondary outcomes (sleep, pain, mood and parental distress) at 3, 6 and 12 months. We
will also assess potential mediators and moderators to allow for future tailoring and refinement. At the
completion of this study, we will have a completely optimized and refined intervention for youth with PPCS
ready for large scale implementation and dissemination.

Public health relevance
PROJECT NARRATIVE More than one million US youth sustain a concussion each year and one in three have symptoms like headache and trouble concentrating lasting longer than a month, described as persistent post-concussive symptoms or PPCS. We developed a collaborative care (CC) treatment approach for youth with concussion, finding benefit from wraparound care including cognitive-behavioral therapy, parenting skills training and care management (including advising families regarding medications). We are now proposing to optimize the CC approach, streamlining it to only include components that are effective, in order to maximize accessibility of this approach as we work towards larger scale implementation and dissemination.